Training in Molecular Therapeutics for Pediatric Cardiology

Summary
Research advances in the field of Pediatric Cardiology have led to both improved clinical outcomes and major
scientific insights. Research training through this NHLBI program has helped to achieve this success by
constantly incorporating new discoveries into the individual training curricula of our mentees. Our NHLBI training
program, now in its 24th year, has demonstrated that our trainees contribute strongly to advances in the field,
while establishing their own independent, productive careers.
The aims of our program are to:
1.To Identify, recruit and foster research trainees, both CHOP cardiology fellows and scientists best suited
for a career focusing on the challenges facing pediatric cardiovascular medicine, who are willing to commit
to training and career development in this field.
2.Match trainee interests and strengths with mentoring teams.
3.Provide mentor training and support.
4.Provide essential resources and novel opportunities for career development, with a goal of graduating
trainees capable of independence.
The objectives of this NHLBI-Postdoctoral Training Program are to:
 Train a cadre of committed researchers to advance the field of pediatric cardiovascular research by
addressing unmet needs.
 Provide these individuals with the skill sets and foundation for career advancement.
 Encourage leadership and innovation.
Goals–to pursue the aims and objectives through a training program consisting of:
 Mentored independent research projects, with a team approach, with requisite mentor training and
scholarship oversight.
 Didactic opportunities, including core requirements and individually selected courses designed to
provide specific research skills
 Seminars, workshops and a journal club focusing on research and progress in the field.
 Career guidance including independent development plans (IDP), seminars and workshops focusing on
professional development and survival skills.
 Fostering a connection with mainstream pediatric cardiology research through participation in CHOP
Cardiology research activities, CHOP Cardiac Center Research, the CHOP Cardiovascular Research
Institute, and The Penn Cardiovascular Institute.

Public health relevance
Narrative Research advances in the field of Pediatric Cardiology have led to both improved clinical outcomes and major scientific insights. Research training through this NHLBI program will continue to build on this success by constantly incorporating new discoveries into the individual training curricula of our mentees. Our NHLBI training program, now in its 24th year, has demonstrated that our trainees contribute strongly to advances in the field, while establishing their own independent, productive careers.